Molecular Insights into Activation and Substrate Recognition of Protein Kinase R

DESCRIPTION (provided by applicant): Abstract: The active PKR kinase domain (KD) phosphorylates the Ser51 residue of translation initiation factor eIF2α. The activation of PKR KD requires precise dimerization and autophosphorylation, including threonine-446 (T446) autophosphorylation in the activation loop. Then, the phospho-PKR (active) recognizes eIF2α and transfers the γ- phosphate of ATP to the Ser51 residue of eIF2α. We hypothesize that, in latent PKR, the activation loop collapses into the active-site cavity, and dimerization of the N-terminal double-stranded RNA binding domains of PKR would cause a precise conformational change of the C-terminal KD dimer. As a result, the activation loop residue T446 is phosphorylated by any of three mechanisms: trans-inter-dimer, cis-intra-dimer and trans- intra-dimer. We will dissect each of these mechanisms, and uncouple the role of dimerization and T446 phosphorylation, in particular, how dimerization promotes T446 autophosphorylation and how T446 autophosphorylation influences dimerization. Also, we will take an electron paramagnetic resonance (EPR) spectroscopy based approach to examine the movement of the Ser51 loop of a cysteine-less eIF2α in the apo-form, in the phosphorylated form, and with/without addition of PKR. PUBLIC HEALTH RELEVANCE: Project Narrative: Protein kinase R is directly involved in anti-viral defense responses and anti-proliferative effects on cancer cells, this fundamental knowledge of PKR will be useful to design anti- viral and anti-proliferative modulators.